Specific Coxsackievirus B3 Binding Interactions with Bacteria

PROJECT SUMMARY
Enteric viruses are infectious human pathogens that lead to significant disease and symptoms such as nausea,
diarrhea, vomiting, and abdominal pain. These viruses spread through the fecal-oral route, initiating infection in
the intestine and traverse through the gastrointestinal tract. Enteric viruses are easily spread by contamination
of food and water and by contact between individuals. Coxsackievirus is a type of enteric virus that causes hand,
foot, and mouth disease, aseptic meningitis, conjunctivitis, and myocarditis. Specifically, Coxsackievirus B3
(CVB3) is the major isolate associated with viral myocarditis. Because CVB3 is an enteric virus and initiates
infection in the gastrointestinal tract, the virus encounters a diverse population of intestinal bacteria. Previous
studies have shown that CVB3 interacts with bacteria and that this interaction enhances viral stability, infectivity,
replication, and pathogenesis. Our lab has also shown that bacteria-mediated enhancement is specific to
bacterial species as well as to species-specific bacterial cell wall components. Notably, Salmonella enterica was
able to enhance CVB3 infectivity, but not Escherichia coli. Furthermore, specific bacterial cell wall components
are able to enhance CVB3 stability. Smooth type LPS from S. enterica was able to enhance CVB3 stability, but
not rough type LPS nor any LPS from E. coli strains. Interestingly, CVB3 is able to bind to both S. enterica and
E. coli despite these differences in bacteria-mediated viral enhancement.
Previous data demonstrate that enteric viruses can bind directly to bacteria, including CVB3. However, it is
unknown if binding trends affect bacteria-mediated viral enhancement or if specific components of bacterial cell
walls are responsible for binding. The overarching goal of this project is to characterize the binding interaction
between CVB3 and enteric bacteria. Our central hypothesis is that CVB3 binds enteric bacteria through specific
LPS structures that dictate binding affinity. To examine this hypothesis, I will perform biochemical binding assays
to identify the specific bacterial cell wall structures that allow for bacterial binding to CVB3. I will also compare
binding affinities between CVB3 and different intestinal bacteria. Experiments outlined in Aim 1 will establish the
role that LPS plays in binding to CVB3 and identify the specific components of LPS that are required for CVB3
binding. Experiments described in Aim 2 will widen the scope of this study by examining differences in CVB3
binding trends to different intestinal bacteria and LPS structures from different bacterial species. Overall, these
data will distinctly characterize the interactions between CVB3 and enteric bacteria. Completion of this project
will reveal more about the mechanisms driving bacteria-mediated enhancement of CVB3 and will provide insight
into potential conserved features between CVB3 and other enteric viruses. This will increase our understanding
of the pathogenesis of enteric viruses and guide future therapeutic avenues.

Public health relevance
PROJECT NARRATIVE Enteric viruses like Coxsackievirus B3 traverse the gastrointestinal tract and encounter a diverse community of bacteria that has been shown to enhance viral pathogenesis. The research proposed here will characterize the binding interaction between CVB3 and enteric bacteria, specifically focusing on the role of specific lipopolysaccharide structures that influence binding. Completion of this project will provide new insights into the relationship between enteric viruses and bacteria, increasing our understanding of viral pathogenesis.